Reliable AI for Medical Image Reconstruction

Project Abstract/Summary
Deep neural networks have enjoyed wide empirical success in a variety of disciplines ranging from computer
vision to natural language processing. However, in medical imaging such as Magnetic Resonance Imaging (MRI),
a variety of challenges including lack of high-quality training data, lack of robustness to corruption/outliers and
distribution shifts between train and test time as well as documented lack of reliability and trustworthiness impede
the wide use and adaptation of AI. This project develops new deep learning-based architectures, algorithms and
training mechanisms that that deals with these challenges creating a new toolkit for MRI reconstruction that is
robust, reliable, trustworthy yet can be trained collaboratively and privately across multiple hospital systems.
Using this new toolkit the project addresses three major MRI reconstruction challenges (1) reducing acquisition
time via higher acceleration factors, (2) enabling high quality reconstruction even with low-intensity magnetic
elds, and (3) dealing with motion artifacts. In collaboration with Musculoskeletal (MSK) sections of a few
major universities, this project also involves gathering, curating and releasing new datasets and open source
reconstruction software aimed at addressing these key challenges. This will also help attract further research from
the machine learning/AI community to further improve this important medical imaging modality.
Healthcare Impact: This project will signi cantly enhance MRI which is an important diagnostic tool. (1)
reductions in the acquisition time will simultaneously increases both the accuracy of diagnosis and patient comfort.
(2) the reduction of noise/nonlinear artifacts caused by low- eld scanners will lead to a reduction in the size and
weight of the MR scanner. This may eventually allow MRI to be used at point of care or for emergency scenarios
at the bedside and also open up a plethora of new use cases. (3) reductions in the motion artifacts increases the
accuracy of diagnosis for a variety of new diseases and conditions enabling new diagnostic use cases for MRI. Also,
(1) allows more patients to receive a scan using the same machine and (2) lowers the cost of the magnet and the
space of operation of MR scanners. This can signi cantly reduce patient cost and thus increase the access to this
diagnostically important medical imaging modality. Furthermore, the focus on MSK data collection can greatly
facilitate accurate diagnosis of pathology such as subtle meniscal tears or chondrites in the knee, labral and rotator
cu tears in the shoulder, and ligament out tears in the wrist. The particular focus on brachial plexopathy is also
expected to have signi cant healthcare bene ts as the briachial plexus is an intricate anatomic structure with the
critical function of providing innervation to the upper extremity, shoulder, and upper chest. The brachial plexus
MRI study will enable great detail of this intricate anatomical structure with low/conventional eld strengths
which is of paramount importance in patient treatment, especially in traumatic settings.

Public health relevance
Reliable AI for medical image reconstruction Project Narrative Modern Arti cial Intelligence (AI) algorithms have immense potential to revolutionize healthcare, however their widespread use/adaptation has so far been stymied due lack of reliability and trustworthiness. This project develops novel reliable AI algorithms for Magnetic Resonance (MR) imaging that can help overcome various physical limitations of MR machines, leading to devices that are signi cantly faster, cheaper and more accurate. This can in turn signi cantly enhance the quality of medical diagnostics and patient comfort while reducing the cost and increasing widespread access to this important medical imaging modality. 1